Bayesian machine learning for complex missing data and causal inference with a focus on cardiovascular and obesity studies

Project Summary
This proposal will develop Bayesian machine learning approaches via Bayesian nonparametrics (BNP) to handle
nonignorable missingness (in outcomes and covariates) and conduct causal inference for electronic health records
(EHRs), to address missingness in multivariate longitudinal data, and for causal mediation problems. Missing
data remains a problem in clinical studies and in particular, for studies using EHRs. In clinical studies, more
effort is spent to try to minimize the amount of missingness, but it still remains a problem and missingness is
a constant issue (and less controllable) in studies based on EHRs. In addition, there has been limited work on
the use of auxiliary information in EHRs that can enhance the ability to deal with missing data. Approaches for
missingness in multivariate longitudinal data is underdeveloped and relevant across many clinical trials settings
from cost effectiveness analysis to incomplete time-varying auxiliary covariates (or confounders) to causal mediation
to multiple outcomes of interest. The mechanisms of treatment effectiveness are of particular interest in behavioral
trials. Specifically, how do different processes mediate the effect of an intervention? This can facilitate constructing
future interventions. However, determining the causal effect of such 'mediators' on outcomes is difficult. We will
develop new approaches to identify these effects in the complex setting of cluster randomized trials for which
little work has been done. For all these settings, a Bayesian approach is ideal as it allows one to appropriately
characterize uncertainty about unverifiable assumptions (which are present in all these problems) and allows the
flexibility of Bayesian nonparametric models. MCMC algorithms for BNP can sometimes converge slowly and can
be untenable for large n. We will extend existing approaches to address both these complications which will be
important for all the applications considered and in general, given the increasing size and complexity of data.
The methods are motivated by several NHLBI funded studies, whose PJ's are co-investigators on this proposal,
and will be developed to help answer numerous important clinical questions including the mechanisms of behavior
change in weight management and the impact of linkage ( and engagement) to care on treatment effectiveness
for blood pressure outcomes. The methods will also help us evaluate potentially synergistic effects when drugs
with potential diabetogenic effects are used concomitantly and whether the impact on cancer outcomes varies by
different bariatric surgeries.
The history of the the collaborations among the entire study team will help produce the best science and
facilitate dissemination of our methodological and clinical findings. We will disseminate code for these methods
(via the PJ's github page and software papers) to ensure the methods will be readily usable by investigators
involved in cardiovascular, obesity, diabetes, and cancer studies.

Public health relevance
Narrative This application will address important public health problems indirectly, through machine learning methods for inference in the presence of missing data and for causal mediation, and directly through constructing these methods to specifically address important reseach questions involving cardiovascular health in underdeveloped settings, weight management in behavioral studies, the impact of the type of bariatric surgery on weight and cancer outcomes, and pharmacoepidemiologic studies of diabetogenic risk in treatment of hypertension and mental disorders.